Structural Racism and Engagement of Family Caregivers in Serious Illness Care

PROJECT SUMMARY
Serious illness is a condition that carries a high risk of mortality and either negatively impacts a person’s daily
function or excessively strains their caregivers. Serious illness affects an estimated 12 million US adults.
Structural racism and racial/ethnic residential segregation may affect serious illness outcomes by 1. limiting
access to palliative care, the specialty focused on improving quality of life for persons with serious illness and
their families and 2. limiting the capacity of family caregivers to engage with the healthcare system. Caregivers
are critical for this population because they assist with complex decision making, care coordination and patient
advocacy. Structural racism refers to the totality of ways in which societies foster racial discrimination through
mutually reinforcing systems (such as housing, education, employment, and healthcare) that ultimately affect
health outcomes. Such institutions include healthcare systems, whose internal cultures may affect care delivery
and patient outcomes differentially by race and ethnicity. Few studies have attempted to highlight racism’s impact
on caregivers. To address this gap, we propose a population-based, multi-level, mixed-methods study within
and across the state of Massachusetts, a diverse state with large limited-resource communities and a population
that includes ~30% persons of color (POC). Focusing on a single state allows for in-depth investigation across
communities that vary in racial composition and resources, as well as across hospital systems that vary in terms
of size, profit status and academic affiliation. In Aim 1 we propose a quantitative analysis that will describe
neighborhood-level burden of serious illness, access to hospital-based palliative care, availability of caregiver
resources, and their impact on individual-level health outcomes. Data from the All Payer Claims Database will
characterize neighborhood-level rates of serious illness and access to palliative care (travel time), and individual-
level health care utilization (hospitalization, palliative care use, length of stay, ICU stay) and health outcomes
(in-hospital death). Mediation analysis with linked data on neighborhood-level caregiver-related resources from
the American Community Survey will identify the effect of neighborhood-level caregiver resources on
outcomes. We hypothesize that poorer access to care, measured as longer travel time to hospitals, will more
negatively affect POC from neighborhoods with fewer caregiver resources. In Aim 2 we conduct qualitative case
studies of hospitals to characterize how hospital cultures support or constrain caregiver engagement for persons
with serious illness from different POC communities. We will conduct n=8 in-depth case studies to characterize
institutional cultures of caregiver engagement. In Aim 3 we convene community, content, and policy experts to
synthesize quantitative and qualitative results to produce culturally appropriate hospital recommendations and
actionable policy solutions to improve equity in caregiver engagement for serious illness. Disentangling the
relationships between segregation, neighborhood deprivation, and healthcare utilization in serious illness will
help us show that racism, not mistrust, is a primary barrier to equitable care and health outcomes.

Public health relevance
PROJECT NARRATIVE An estimated 12 million US adults are living with serious illness, a condition that carries a high risk of mortality and excessively strains their caregivers. Structural racism and racial/ethnic residential segregation may affect health care for patients with serious illness by limiting access to palliative care, the specialty focused on improving quality of life for persons with serious illness and their families and limiting the capacity of family caregivers to engage with the healthcare system. We will conduct at population-based, multi-level, mixed- methods study within and across the state of Massachusetts to disentangle the relationships between residential segregation, neighborhood deprivation, and healthcare utilization in serious illness in order provide evidence that racism, not patient mistrust, is a primary barrier to equitable palliative care and health outcomes.